RCT Targeting Cognition in Early Alzheimer's Disease by Improving Sleep withTrazodone (Rest)

Project Summary - Abstract
It is estimated that 5.8 million people are afflicted by dementia in the US, a number projected to
increase to 14 million by 2050 unless effective therapies are available that prevent or
significantly slow the disease process. Sleep complaints are common throughout the AD
continuum beginning with prodromal stages. In observational studies, disturbed sleep has been
linked to AD pathogenesis and subsequent development of mild cognitive impairment (MCI) and
dementia. Co-investigator Dr. Bakker has studied pattern separation (PS; a memory task
involved with the earliest stages of encoding that is essential to formation of new memories) in a
task related functional MRI (fMRI) paradigm, determining that impaired PS is associated with
increased hippocampal activation in amnestic MCI (aMCI). Because poor sleep may be
associated with increased hippocampal activation, improving sleep is a potential target for
positively affecting cognition and disease progression in AD. Trazodone is a generic
antidepressant widely used off-label to treat sleep disturbance, particularly enhancing slow
wave sleep (SWS) that is evidenced to be a critical sleep phase influencing pathogenic
mechanisms. While it has been demonstrated to improve sleep in AD and potentially mitigate
the risk of developing MCI, its effect on sleep has not been rigorously studied in MCI.
Supported by its benign safety profile, we propose a rigorous double-blind, placebo-
controlled, randomized crossover trial of trazodone in 100 subjects with prodromal
AD/aMCI and sleep complaints. Each treatment phase will last four weeks with a two-week
washout between phases. Sleep will be measured by home sleep testing including
polysomnography, actigraphy, and self-report. Hippocampal function and excitability will be
assessed by task-related fMRI employing PS. The primary outcome will be to examine the
association of trazodone with sleep parameters. We hypothesize that trazodone will improve
total sleep time and proportion of time in SWS. Secondary outcomes include assessment of
trazodone's effect on 1) PS and hippocampal activation by task-related fMRI, with the
hypothesis that trazodone will improve PS performance and decrease hippocampal activation;
2) a broader range of cognitive domains, with the hypothesis that trazodone will improve
performance on other memory tasks, executive function, and processing speed; 3)
neuropsychiatric symptoms with the hypothesis that they will improve with trazodone treatment.
We will also assess blood-based biomarkers of amyloid and tau, as exploratory outcomes to
assess their association with sleep and cognitive responses to trazodone.

Public health relevance
NARRATIVE Persons with very early stages of Alzheimer's disease (termed Mild Cognitive Impairment [MCI]) often have problems with sleep, and there is evidence that poor sleep may contribute to cognitive decline. Trazodone is an FDA-approved medication widely used off-label to improve sleep and has a favorable side effect profile in older adults. We propose a randomized, controlled crossover trial comparing the effect of 1 month trazodone vs. placebo in 100 older adults with MCI and sleep complaints, and hypothesize that trazodone will not only improve sleep but improve a type of memory (pattern separation) and improve hippocampal function (evidence by functional MRI).